HIV CO-INFECTIONS IN UGANDAAdministrative Supplement for Research and Capacity Building Efforts Related to Bioethical Issues (Admin Supp Clinical Trial Optional)

Background: Knowledge of research ethics principles and their practical application and ethical
theory are not consistently integrated in curriculum requirements in health disciplines training.
Research in people living with HIV (PLWH) in resource limited settings (RLS) may pose
additionally bioethical challenges for which it is imperative that trainees are exposed to research
bioethical training before carrying out research activities
Aim. We plan to develop a training program with a blended approach of class training,
development of role-plays and case scenarios, and web-based modules to address gaps and
equip trainees of the School of Medicine at Makerere University with knowledge in ethics
principles in research with PLWH.
Specific objectives 1. To understands the training needs in research bioethics for trainees in the
area of HIV and co-infections. 2.To develop a short training curriculum comprising class training,
including role plays and case scenarios and web-based modules for online training for trainees at
the School of Medicine. 3.To pilot and evaluate the developed training, refine and complete the
teaching material and content. At the end of the grant this content will be officially handed over to
the School of Medicine and the course will be offered annually (post award) as part of the School
of medicine training.
Methods
We plan to conduct a formative phase consisting in a survey of trainees, and in depth interviews,
and coordinate the training material with the mentors and the implementation of the training.
The findings will guide the development of the training material and content, focusing on complex
and understudied populations within PLWH, such as children, adolescents, pregnant and lactating
women, elderly people living with HIV, “most at risk population” (e.g. commercial sex workers,
sexual minority men, transgender individuals, drug users), and very sick hospitalized patients.
We will organize a pilot training course followed by a formal evaluation consisting of a survey and
interviews with the trainees. Based on the feedback the training program will be refined and
finalized and will be integrated in the teaching modules of the School of Medicine

Public health relevance
With this grant we intend to develop a course that will address gaps in bioethics training on HIV related research for the trainees of the School of Medicine at Makerere University: this training may also address gaps in research with other vulnerable groups and the general population. Additionally, to traditional class training we will develop web-based modules that can be accessed beyond the training period. The curriculum will be integrated in the teaching modules of the School of Medicine and the online training component on the Infectious Diseases Institute e-learning platform will also be accessible to trainees or staff of other academic institutions via free registrations with the platform.